NCI-VA Collaborations

We are looking at utilization and trends of genetic testing and drug emergent cardiotoxicity after treatment with tyrosine kinase inhibitors. This year, we would like to explore adverse drug events (ADE) associated with cardiotoxicity in tyrosine kinase inhibitors.